Healthy Brain and Child Development National Consortium Data Coordinating Center

PROJECT SUMMARY
The landmark Healthy Brain and Child Development (HBCD) study will provide a representative reference data
resource to the scientific community enabling unprecedented investigation of neurodevelopment and the impact
of environmental, genetic, and biological factors on brain and behavioral health and developmental trajectories
from infancy through childhood. Through this study, the Healthy Brain and Child Development National
Consortium (HBCD-NC) will recruit and retain a sociodemographically diverse cohort of 7,500 pregnant women
from 24 sites across the U.S. and follow these families and their children through the first decade of life. Children
will undergo rigorous data collection across modalities including neuroimaging, neurophysiology, behavioral and
cognitive assessments, and collection of biospecimens via a balanced protocol developed by field-leading
experts. Building upon the substantive complementary experience and expertise of its multidisciplinary team and
leveraging multiple population-specific technical innovations, the Healthy Brain and Child Development National
Consortium Data Coordinating Center (HDCC) will provide the leadership, management, and oversight of data
collection, quality control, curation, processing, management, sharing, and analytics to facilitate and support the
activities of the HBCD-NC and ensure its success. Included is development and implementation of an optimized,
state-of-the-art MRI protocol harmonized for the first time in infants/toddlers across all three major vendors which
leverages the latest innovations in scanner technology with age-specific structural, microstructural, quantitative,
functional, and spectroscopy sequences. Also detailed is a targeted EEG protocol linked with a field-leading
automated processing pipeline for developmental EEG which provides innovative derivative measures. Data and
project management will occur through a centralized tracking and distribution platform linked to a high-throughput
compute backbone which overcomes limits of commercially-available systems for management and integrated
processing of multimodality data from large, multi-site studies. High performance computing will be supported
through unique access to a combination of field-leading resources. Detailed procedures are outlined for secure
collection, management, and analysis of personally identifiable information (PII) data, including flexible methods
designed to accommodate heterogeneity in electronic health record systems across sites. Finally, substantive
HBCD-specific enhancements to the Data Exploration and Analysis Portal (DEAP 2.0) will produce a crucial tool
for data access to authenticated users while promoting best practices in reproducible statistical analysis and
providing flexible computation without the need to download restricted-access data. The result of this field-
leading combination of HDCC resources will be a state-of-the-art, longitudinal data set of unparalleled scale
which provides deep understanding of the biological and environmental factors that affect a child’s health, brain,
and behavioral development and shapes research, clinical care, and public policy for decades to come.

Public health relevance
PROJECT NARRATIVE The Healthy Brain and Child Development (HBCD) study will establish a state-of-the-art, longitudinal data set from a cohort of 7,500 mother-child dyads that will address essential questions regarding the impact of high-risk environments, including prenatal substance exposure, on brain and behavioral health and developmental trajectories. The project will include multi-site data collection across a wide range of modalities including harmonized neuroimaging, neurophysiology, behavioral and cognitive assessments, and the collection of biospecimens. The proposed HBCD National Consortium Data Coordinating Center will provide the leadership, overall management, and primary oversight of all data collection, quality control, storage, management, sharing, and analytics necessary to ensure the project’s success.